Leveraging Adaptive Evolution and High-Throughput Techniques to Dissect the Link Between Biochemical Function and Fitness

PROJECT SUMMARY/ABSTRACT
Enzymes are the primary functional molecules in cells, providing enormous rate enhancements,
specificity and regulation to the diverse chemical reactions that are necessary for life. Enzymes, like all biological
macromolecules, are the products of evolution: all enzymes have evolved to operate within the complex
environment of the organism/cell in specific environmental niches(s). Thus, an understanding of enzyme function
and evolution is fundamental to biology. Enzymes also have tremendous potential in medicine (e.g., as targets
for anti-cancer, antimicrobial and antiviral drugs and as therapeutics for metabolic disorders) and in industry (e.g.
to make important commodity chemicals and as catalysts for bioremediation). Our central premise is that a
quantitative, mechanistic understanding of enzyme function and its relationship to organism fitness is critically
needed to precisely manipulate enzymes and to deeply understand biology.
To generate this level of understanding, we need: (1) a quantitative, chemical, and physical knowledge
of enzyme function, and (2) mechanistic data describing how and when these physical principles contribute to
enzyme function within the complex environments where enzymes operate. An enhanced understanding of the
relationships between protein sequence, protein function and cellular/organismal fitness will have profound
impacts across biology and medicine, from improving our ability to predict how mutations will influence the
virulence and drug susceptibility of human pathogens, to enhancing precision medicine by accurately predicting
the consequences of allelic variants, to enabling the design of next-generation protein and cellular therapeutics.
Achieving this understanding requires new tools and a new conceptual paradigm. Enzymes are highly
interconnected, their functions are multifaceted, and their cellular environments are complex. Traditional
biochemistry is enormously powerful, allowing for the intensive study of a few individual enzymes in vitro (10s)
and providing detailed knowledge of their chemical mechanisms. But identifying the many residues that matter
for enzyme function requires investigation of residues beyond the active site at a scale far beyond that of
traditional biochemistry. Furthermore, this biochemical information then needs to be translated to organism
fitness in vivo in a quantitative manner. Here we will overcome these challenges. We will first use evolutionary
sequence information to direct enzyme variant design towards functionally important areas of sequence space.
We will adapt high-throughput microfluidic technologies to quantitively measure the biochemical properties (e.g.,
kcat, Km, Ki, and ∆GFold) of this library of 104 enzyme variants in vitro (Aim 1). Then we will determine how each
of these variants affects organismal fitness in vivo using pooled competition and barcode sequencing assays
(Aim 2). Finally, we will use this sequence-function-fitness map to test long-standing models in biochemistry and
evolution and reveal the biochemical determinants of fitness important for industry and medicine (Aim 3). Such
a comprehensive and quantitative mapping of biochemical function to fitness has never been achieved.

Public health relevance
PROJECT NARRATIVE Enzymes are central to biology and a physical understanding of enzyme function in vitro and in vivo has far- reaching implications in medicine and industry. Here we will leverage adaptive evolution and high-throughput technologies to build the first map between enzyme sequence, enzyme function and organism fitness. This sequence-function-fitness map will allow us to address many important questions in biochemistry and evolution and will usher in a new era of integrative biochemical evolution studies.